CHILD CARE AND EARLY EDUCATION RESEARCH CONNECTIONS

Child Care & Early Education Research Connections (RC) promotes high-quality research in child care and early education and the use of research findings in policymaking. This easy-to-use website page offers a free, comprehensive, and up-to-date collection of scholarly research, policy briefs, government reports, datasets, and instruments from a wide range of disciplines and sources. Interactive tools allow users to refine searches, download full text documents, build customized tables, and analyze data on line. RC also compiles bibliographies, develops issue briefs, synthesizes research on key topics, and hosts data-training workshops and webinars.